Single Cell RNA Sequencing (scRNA-seq) Instrumentation

PROJECT SUMMARY
We propose to acquire a benchtop cell sorter which will be paired with a cell partitioner in order to establish a
single cell RNA sequencing (scRNA-seq) sample preparation instrument This shared instrumentation provides
maximum flexibility for investigators and will be the only instrument of its kind on the University of Arkansas (U
of A) campus and Northwest Arkansas area. The instrument will be housed within the Engineering Research
Center, a facility with the infrastructure and personnel necessary to support its operation. In support of this
effort, a cohort of 6 Major and 12 Minor Users have been identified that represent the largest individual needs
for single cell analysis capabilities at the U of A. These users represent a mix of established and early-career
investigators and reflect the dynamic and growing need for single cell analysis. Together, the Major and Minor
users hold grants from the NIH (10), NSF (4), USDA (2) and State sources (2) and are projected to comprise
approximately 85% of the instrument’s Accessible User Time (AUT) in the first year of operation. Additional
usage is anticipated from additional pilot project users with less substantial (<1% AUT), but still meaningful,
scRNA-seq requirements. The proposed instrument will be part of a vibrant ecosystem of resources at the U of
A. Together, these resources will ensure the successful deployment of the scRNA-seq instrument and
maximize its usage by the U of A research community. This shared resource will enjoy significant financial and
administrative support and receive strategic guidance from the Advisory Board. The instrument will be used to
advance numerous projects related to cancer, wound healing, aging, diabetes, inflammation, neuroscience,
and food safety. The scRNA-seq instrument proposed here will have an immediate and lasting impact on
research productivity at the U of A, allowing users to design more robust experiments, make more efficient use
of grant dollars, and conduct the best science possible, benefits that are consistent with the University’s
commitment to growing its biomedical research endeavor.

Public health relevance
NARRATIVE The acquisition of single cell RNA sequencing (scRNA-seq) sample preparation instrumentation will allow users to measure and examine the transcriptome both across and within individual cell types. These measurements will provide new insights into cellular heterogeneity in cancer, wound healing, and neurological disorders, as well as advance therapeutic design, development, and delivery. Therefore, the findings enabled by this instrument will advance research in numerous areas that will lead to reducing the burden of disease.